Community Partnership for Telehealth Solutions to Counter Misinformation and Achieve Equity (PRIME)

ABSTRACT
Use of cancer screening services for Latinx populations has lagged far behind the use for non-Latinx White
populations; this has led to later stage detection and worse survival for Latinx people. Clinic-delivered video-
texting combined with neighborhood-level navigation services is a telehealth-community solution that offers
great promise for addressing cancer screening disparities, as it reduces multi-level barriers to care. Our
proposed project, Community Partnership for Telehealth Solutions to Counter Misinformation and
Achieve Equity (PRIME), will leverage partnerships among research centers, clinics, and community
organizations to provide personalized support services informed by local knowledge and neighborhood-level
data, and apply and evaluate novel technical and communication solutions. The goal of PRIME will be to
improve colorectal cancer-related care delivery and reduce disparities in telehealth access and care by
developing and testing telehealth tools and technologies using novel research methods. This research will use
rapid methods and adaptive-evaluation processes and will apply the Health Equity Implementation Framework
and components of the Reach Effectiveness-Adoption Implementation Maintenance (RE-AIM) framework, with
an emphasis on effects on disparities in implementation and evaluation. PRIME will assess neighborhood-level
social determinants of health and adapt and optimize a telehealth-solution to improve the quality, reach, and
effectiveness of colorectal cancer screening in predominantly Latinx clinic populations aged 45-54 (Aim 1); test
technical and communication solutions that use video-text messages to educate patients about colorectal
cancer screening, link them to community-based services, and provide personalized navigation to support to
improve uptake of screening and follow-up care, using a pragmatic stepped-wedge design (12 neighborhoods;
3,000 patients aged 45-54; Aim 2); and assess multi-level moderators of program effectiveness (including
neighborhood-level social determinants of health, ethnicity, and preferred language) and organizational-level
barriers and facilitators to implementation; and scale-up the program across neighborhoods and partnering
clinical practice sites (n = 4; Aim 3). This project will leverage local resources and strengthen connections
among health systems and trusted community-based organizations, increasing the likelihood of program
sustainment. To ensure the project’s success, we have assembled an engaged group of community partners,
including payers, health centers, community-based organizations, and patients, along with a multi-disciplinary
research team of nationally renowned clinicians and scientists. If successful, the program will result in ready-to-
implement strategies to reduce cancer-related disparities and improve preventive cancer care access, quality,
and health outcomes for Latinx populations.

Public health relevance
NARRATIVE Colorectal cancer screening among Latinx populations lags far behind that of non-Latinx White populations. We will test a program that pairs video-texting with neighborhood navigation services to improve colorectal cancer screening for adults who are new to screening or have never been screened. Our program could serve as a model for sharing accurate health information and promoting healthy behavior for a variety of diseases.